New Methods and Strategies for the Synthesis and Selective Derivatization of Natural Products

Project Summary/Abstract
These studies are focused on developing new catalytic approaches and strategies to improve the
availability of cardiotonic steroids, bioactive terpenoids, alkaloids and glycosylated natural product-based
molecules of therapeutic value. Due to the importance of steroidal hormones for the regulation of vital biological
processes in the human body, many members of the terpene family of natural products possess a wide spectrum
of biological activities. In particular, cardiotonic steroids have many centuries-long history of serving as effective
drugs for the treatment of various heart conditions. In addition, many recent studies suggest that these
compounds hold great potential as the therapeutic agents for the treatment of cancer, neurodegenerative
diseases, inflammation, immune and metabolic diseases, and in various important health-related areas such as
pain relieve. The developed in these studies new synthetic approaches could significantly improve the availability
of otherwise difficult-to-access stereoisomeric cardenolide scaffolds with unusual substitution or oxidation
patterns, and one of our objectives is to conduct the medicinal chemistry exploration of various natural and
unnatural cardiotonic steroids. The techniques developed in this project will also improve the accessibility of
related natural products such as bioactive animal- and plant-derived bufadienolides with unusual structural
features as well as alkaloids, diterpenes, and plecomacrolides of dippinine, grayanotoxin, and concanamycin
families. To facilitate these synthetic studies, we will produce new catalytic techniques and strategies that will
enable a direct and straightforward glycosylation of complex natural products and synthesis of valuable building
blocks. One of the important objectives of these studies will be developing new sustainable methods that will
streamline and simplify the synthesis of natural products and therapeutic agents.

Public health relevance
Project Narrative The continuing advancement of molecular medicine requires a constant access to more diverse subsets of small-molecules, which are not well represented among the known drug candidates. Chemical synthesis is one of the most important means used to gain access to such compounds. The development of conceptually novel approaches that will aid the synthesis of bioactive molecules and new therapeutic agents is the subject of these studies.